A model system to study the inheritability of structural racism and discrimination through epigenomics

ABSTRACT
Structural racism and discrimination (SRD) is a salient mechanism perpetuating racial gaps in health.
Emerging studies have documented the impact of SRD on negative pregnancy outcomes, including higher
rates of preterm birth among African American (AA) women and higher rates of mortality among AA mothers
and infants. Often an underexplored population, women during the preconception period are a critical group
impacting this disparity, as exposures during pre-pregnancy period significantly impact the mother-infant dyad
across the lifespan. In particular, studies document that the pervasive and lasting impact of chronic stressors
due to SRD, may affect AA women of childbearing age by creating a “weathering” effect, that is associated with
inflammation and distinct epigenetic patterns, which can lead to deleterious outcomes postconception. There
is a critical need to explore the etiologic pathways during the pre-pregnancy period that are influenced by SRD-
related trauma and contribute adverse outcomes in the mother-infant dyad.
Trauma/stress exposure can impact the health of individuals from historically marginalized groups through
modifications to the epigenome, which can induce changes in gene expression affecting the regulation of
physiologic responses including endocrine, immune, cardiovascular systems, etc. Considering AA women
carry a disproportionate burden of incidence, morbidity, and mortality from chronic diseases, it is important to
examine how preconception trauma from SRD alters the epigenome in women of childbearing potential. These
stress-induced epigenetic modifications can be carried forward through the germline, to the potential detriment
of successive generations. Thus, we hypothesize that elevated SRD-related stress in AA women is associated
with epigenetic signatures of inflammation and innate immune dysfunction during the preconception period,
promoting a suboptimal environment for pregnancy. These distinct epigenetic alterations will be inherited in the
offspring via specific germline differentially methylated regions. This proposal will leverage an ongoing R01 to
investigate the impact of SRD-related stress on women prior to conception and we will include a longitudinal
cohort of mother-infant pairs from early gestation to 12-months following delivery to evaluate the transmission
of SRD-related epigenetic signatures from mother-to-child. Three specific aims are proposed: 1) To determine
the burden of structural racism and discrimination on stress, systemic inflammation, and epigenetic signatures
among preconception AA women and 2) To define the longitudinal impact of maternal SRD-related stress on
the inheritance of distinct epigenetic signatures in the offspring. This proposal offers an exceptional
opportunity to understand the etiology of adverse pregnancy outcomes in AA women and identify the
biomarkers and mechanisms that underlie the lasting biological effect of SRD, as these correlates impact not
only at an individual level but also generational.

Public health relevance
NARRATIVE Preconception risk factors associated with maternal and infant mortality are more common among African American women of reproductive age and these disparities are rooted in structural racism and discrimination (SRD), which is a salient mechanism perpetuating racial gaps in health. This proposed study seeks to investigate the etiologic pathways during the pre-pregnancy period that are influenced by SRD-related trauma and to determine the longitudinal impact on the epigenome in the mother-infant dyad. Results from these studies may inform future interventions to address health disparities among at-risk mother-infant pairs and can promote their overall health and well-being.